INVESTIGATION OF BONE DISEASE IN PATIENTS WITH INFLAMMATORY BOWEL DISEASE

To better understand the nature of the bone disease in inflammatory bowel disease and to possibly reverse or prevent further progression of bone disease, subjects will undergo a baseline and 12 month special x-ray study of their bones that measures bone density. Subject, who have been requiring oral corticosteroid therapy or if their bone density is abnormal, will be given calcium and vitamin D supplementation.